Computational and Technical Support for Clinical Trials and Physics Research for

This core C provides services, developments and infrastructure to support: (1) treatment planning and delivery activities for MGH for patients enrolled on clinical trial protocols, including protocol treatments using IMRT, 3D CRT and SOBP and PBS treatment fields; (2) quality, dosimetry and technical validation of protocol design and delivery, including quantifying workflow efficiencies and analysis of workflow safety modes; (3) advancement of optimization technologies in support of PBS treatment planning in the presence of time-dependencies and physical uncertainties; (5) a framework for development and deployment of treatment planning and verification resources in support of the above aims; and (5) Cloud-based access for other POI participating centers to deployed resources. This core supports the mission of the NCI to improve the treatment and continuing care of cancer patients.

Public health relevance
RELEVANCE (See instructions): This research aims to improve radiation treatment for cancer patients by improving our ability to direct the radiation at the tumor to spare adjacent normal tissue by using protons (charged particles) with intensity- modulated proton therapy. This can potentially improve cancer cure rates, reduce side effects, or both, depending on the clinical scenario. With an increasing number of proton centers in the United States and abroad, the research in this program project is increasingly important for public health.